Novel computational methods for higher order diffusion MRI in autism

DESCRIPTION (provided by applicant): The diagnosis of autism spectrum disorder (ASD) is currently based on behavior and developmental history of the child. With the development of advanced forms of diffusion-weighted magnetic resonance imaging (DW-MRI), it is expected that imaging will elucidate pathology-induced and neuro-developmental changes in white matter (WM) architecture, and provide diagnostic and predictive anatomical biomarkers. We aim at developing computational methods for processing and analysis of high angular resolution diffusion imaging data that has been fitted with higher order diffusion models (HOMs). Compared to the tensor model in diffusion tensor imaging (DTI), HOMs provide a much richer understanding of pathology-based connectivity changes in complex WM regions, as well as a quantification of the degree of abnormality of WM. These imaging measures when correlated with clinical measures of symptom severity will provide additional insight into the pathology and its progression, thus making this project very clinically significant. Understanding such complex WM regions is expected to aid in the study of ASD, deficits in which can be linked with WM abnormalities and disruptions in structural connectivity via fiber tracts. The advances in acquisition of data that can be fitted with HOMs in turn calls for novel automated tools for analyzing such data, as existing methods developed for tensors are inapplicable to HOMs. We propose to achieve this by the following specific aims: In Aim 1, we will define local and global measures from HOMs and use these to obtain a feature-based algorithm for deformable registration of HOM images preparing them for subsequent analysis. In Aim 2, we will develop and validate an integrated framework for population statistics of HOMs using a combination of voxel-based, manifold-based and tract-based analysis. In Aim 3, we will design high- dimensional multivariate pattern classifiers using HOM features, to obtain spatial patterns of brain abnormality and assign an abnormality to each brain. In Aim 4, we will apply the methods developed in Aims 1 - 3 to a large database of ASD patients and demographically balanced typically developing volunteers and identify patient-control differences and correlate with clinical ratings of symptom severity in patients. The quantification of patterns of group differences and connectivity disruptions are expected to provide insight into the deficits observed in autism such as impaired social interactions, impaired language and communication and stereotypical, restricted and repetitive behaviors. The use of HOMs that has never been attempted before in literature to study ASD, with most of the work limited to the analysis of anisotropy and diffusivity measures computed from DTI data. We expect that upon successful completion of the project, we have developed a general and comprehensive, mathematically consistent and computationally efficient processing and analysis paradigm for large population studies using HOMs that will help identify and quantify complex patterns of connectivity changes induced by pathology.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims at developing computational methods for analyzing diffusion MRI data fitted with higher order models that uniquely characterize complex white matter regions, affected in Autism Spectrum Disorder (ASD). These well validated methods will be applied to the analysis of an ASD population to produce a quantification of abnormalities in brain connectivity and white matter integrity. Correlation with clinical diagnostic measures will provide an image-based link to deficits observed in autism such as impaired social interactions, language and communication and restricted and repetitive behaviors, and hence aid in prognosis and in studying disease progression. Project narrative This project aims at developing computational methods for analyzing diffusion MRI data fitted with higher order models that uniquely characterize complex white matter regions, affected in Autism Spectrum Disorder (ASD). These well validated methods will be applied to the analysis of an ASD population to produce a quantification of abnormalities in brain connectivity and white matter integrity. Correlation with clinical diagnostic measures will provide an image-based link to deficits observed in autism such as impaired social interactions, language and communication and restricted and repetitive behaviors, and hence aid in prognosis and in studying disease progression. __SpecificAimsTextDelimiter__ Specific Aims The diagnosis of autism spectrum disorder (ASD) is currently based on behavior and developmental history. With the development of advanced forms of diffusion-weighted magnetic resonance imaging (DW-MRI), it is expected that imaging will elucidate pathology-induced and neuro-developmental changes in white matter (WM) architecture, and provide diagnostic and predictive anatomical biomarkers. Studies in ASD [1] have demonstrated extensive deficits in multiple domains of social cognition including social communication, face processing, and theory of mind skills. These deficits have been associated with abnormal activity in a number of brain regions such as fusiform gyrus, superior temporal sulcus, medial prefrontal cortex and amygdala. In addition, MRI based studies have supported the finding that children with autism have enlarged brains, and a disproportionate increase in WM vs. gray matter (GM), suggesting differences in WM tracts and hence structural connectivity. In fact, there is a very interesting convergence of data and speculation that ASD may involve an overabundance of short range fiber connections and a decrease of long range connections. These tracts contain regions of complex WM, where there is a possibility of fiber crossings and branchings, which cannot be modeled by diffusion tensor imaging (DTI), where tensors are fitted to the diffusion data at each voxel. This has prompted the fitting of higher order models (HOMs) to diffusion data, acquired with a large number of gradient directions, in order to address the modeling of tissue in complex WM regions. This in turn calls for novel automated tools for analyzing data fitted with HOMs as existing methods developed for tensors are inapplicable to HOMs. We propose to develop computational methods that will address and alleviate the issues with pre- processing and analysis of data fitted with HOMs, through the following specific aims: Aim 1: HOMs measures and spatial normalization. To 1) develop scalar diffusion measures and connectivity maps from HOMs; and 2) use these measures and maps to develop and validate a feature-based deformable registration algorithm for HOM images preparing them for subsequent analysis. We hypothesize that the HOM metrics will be more sensitive to white matter alterations in autism compared to the tensor-based measures that are presently in widespread use and produce better registration. Aim 2: Population statistics on HOMs. To develop and validate an integrated framework for population statistics of HOM measures developed in Aim 1. We hypothesize that statistical analysis of HOM-based connectivity maps will reveal more disease-induced changes in connectivity in long range and short range fibers, important in the study of ASD, compared to traditional DTI based measures. Aim 3: Multivariate Pattern Classification of HOMs. To design and validate high-dimensional multivariate pattern classifiers using HOM features and obtain an abnormality score for each subject. We hypothesize that, in addition to elucidating patterns of abnormality, these classification scores will act as a quantifiable supplement to diagnosis and help classify individuals based on their degree of pathology, in addition to elucidating patterns of abnormality. Aim 4: Application to ASD population. To extensively test the clinical utility of these methods in the clinical investigation of ASD by applying them to data collected through two already funded grants (PIs Schultz and Roberts, respectively): one focusing on social deficits and brain correlates, and the other on language difficulties and brain correlates in ASD. These datasets with matched typically developing controls provide a large and thoroughly characterized set of data. Specifically, we propose 1) to identify tract-wise and voxel-wise differences in structural connectivity and WM integrity between participants with ASD and controls identified via statistical analysis and classifier scores; 2) to correlate WM abnormalities, with indices of core ASD symptom severity including social and language deficits that are the focus of the two companion grants, as well as with emerging electrophysiological (MEG) biomarkers of ASD. We hypothesize that 1) the proposed combination of statistical analysis and pattern classification will elucidate diverse patterns of abnormality in WM integrity and connectivity and 2) these imaging markers will be predictive of symptom severity and MEG observed abnormalities in system timing. Disruptions in these WM connectivities and consequent cortical function are hypothesized to be linked with clinical and behavioral deficits observed in autism such as impaired social interactions, impaired language and communication and stereotypical, restricted and repetitive behaviors. We expect that upon successful completion of the project, we will have developed a general and comprehensive, mathematically consistent and computationally efficient processing and analysis paradigm for large population studies using HOMs that will help identify and quantify complex patterns of connectivity changes induced by pathology. The methods will be applied to ASD in the current project however they are general enough to be applied to any population study based on HOMs.